DYRK1A Inhibition as a Novel Treatment Approach for Alzheimer's Disease

Alzheimer's disease (AD) is an increasingly common and devastating neurodegenerative disease with
no available disease-modifying treatments. Most treatment approaches attack a single disease component,
either the β-amyloid or tau protein pathways, for example. However, pleiotropic interventions will likely be
needed. The dual-specificity tyrosine phosphorylation-regulated kinase 1A (Dyrk1a) protein represents one
such target, with activity in β-amyloid, tau, and neuroinflammatory pathways. Each of these pathways
contributes to neurodegeneration and cognitive deficits in AD. As such, compounds that inhibit Dyrk1a offer a
promising new therapeutic approach through novel simultaneous modulation of tau, amyloid, and
neuroinflammatory pathways. To this end, our medicinal chemistry efforts have delivered a potent and brain
penetrant molecule, Dyr219, which upon dosing in the 3xTg-AD model, improves behavioral and both tau and
amyloid neuropathological features of AD with no overt adverse effects (Branca et al., Aging Cell, 2017, 16(5),
1146-1154). In a recent extended 6-month study, we observe no motor effects in wild-type or 3xTg-AD mice
following chronic daily dosing, and larger reductions to insoluble, hyperphosphorylated tau, neurofibrillary
tangles and insoluble Aß42 peptides and amyloid plaques. Recently, we have confirmed that Dyr219 also triggers Dyrk1a protein degradation, assigned to inhibition of the Dyrk1a autophosphorylation process. This effect reduces levels of active Dyrk1A in vivo, contributing to efficacy and pointing to a PK-PD relationship between Dyr219 brain exposure and robust neuropathological effects. Ongoing medicinal chemistry efforts directed at enhancement of oral bioavailability and kinome selectivity have recently delivered significantly improved analogs (Dyr476: F% 73%, B/P 0.39) and (DYR533: F% 100%, B/P 0.30 S(35)-selectivity score 0.03). Importantly, Samumed has recently announced the discovery of SM07883, an IND-ready, potent, oral Type 1 Dyrk1a inhibitor which exhibits significant tau pathology
reduction in JNPL3 mice. We feel the latter validates the feasibility of our short-term pre-clinical hypothesis and
supports the necessity of the aims described herein. In summary, we propose a robust medicinal chemistry pipeline, coupled with in vivo testing of promising compounds in mice, with the aim of delivering molecules superior to Dyr219 that address oral bioavailability, are deemed safe in pre-clinical toxicology models and recapitulate its in vivo effects. We expect our new molecules to be effective at modifying the course of pathology and cognitive decline in AD.

Public health relevance
With 24.3 million people affected worldwide in 2005 and an estimated rise to nearly 45 million in 2020, Alzheimer's disease is a leading unmet medical need. The goal herein is to optimize oral bioavailability and kinase selectivity of an efficacious proof-of-concept DYRK1A inhibitor and evaluate an optimal candidate in 3xTg-AD and JNPL3 mouse models of AD. Such a molecule may have potential as a disease-modifying therapy through unique dual targeting of tau and amyloid pathologies.